Scaling Low-Barrier Care to Engage People with Complex Needs in HIV Treatment

Engaging the most vulnerable people with HIV in treatment is central to efforts to end the HIV epidemic. Low-
barrier care (LBC) is an evidence-based multicomponent intervention that includes walk-in access to medical
care, incentives for clinic visits and viral suppression, intensive support to address social determinants of health,
and multisectoral service coordination. The Max Clinic in Seattle is a flagship LBC clinic that has substantially
improved viral suppression among people with complex barriers to care, including unstable housing, substance
use, and mental health disorders. Expanding LBC is central to the Ending the HIV Epidemic (EHE) plan in King
County, Washington. The overall goals of this 5-year proposal are to study LBC expansion in King County,
identify factors that facilitate LBC implementation, and prepare for the intervention’s scale-up in other EHE
jurisdictions. The team will employ a multifaceted implementation strategy to establish and improve two new LBC
clinics in addition to the Max Clinic. We will use the Reach, Effectiveness, Adoption, Implementation &
Maintenance (RE-AIM) framework and structured tools to assess intervention adaptation and scalability. For Aim
1, we will evaluate the reach and effectiveness of LBC expansion in King County using a population-based
observational open cohort design. For Aim 2, we will describe the implementation and maintenance of LBC in
King County, including intervention adaptations, organizational strategies to overcome barriers, and costs. Using
the Framework for Reporting Adaptations and Modifications-Enhanced (FRAME), we will conduct focus group
discussions with key stakeholders in the LBC clinics and the health department at baseline and conduct brief re-
assessments in six-month intervals over four years to describe intervention adaptations and elucidate
implementation and maintenance strategies. We will quantify the costs of LBC expansion from the health
department and healthcare organization perspectives using micro-costing methods. For Aim 3, we will assess
the scalability of the LBC intervention and identify a consortium of health department and clinic leaders to scale-
up LBC in cities and states prioritized for the first phase of EHE funding throughout the U.S. We will partner with
NASTAD (the National Association of State & Territorial AIDS Directors) to identify health department HIV
program leaders supportive of LBC implementation, and in collaboration with them, recruit leaders of Ryan
White-funded HIV Clinics or Community Health Center clinics. We will conduct in in-depth interviews with both
the health department and clinic leaders using the Intervention Scalability Assessment Tool (ISAT) for applied
assessment of LBC implementation considerations in each local context. Expected Outcome: Our results will
guide optimization of LBC implementation, inform intervention adaptations, and lay the groundwork for strategic
scale-up of LBC in other parts of the country, which will in turn, advance progress toward achieving EHE goals.

Public health relevance
Public Health Relevance Statement Ending the HIV epidemic in America will require effective delivery of treatment to all people living with HIV. Low-barrier care improves access to HIV treatment for people with complex medical and social needs who have not done well with regular medical care. We will study the expansion of low-barrier care in Seattle/King County, Washington and prepare for scale-up of low-barrier care in other parts of the United States.